IMMUNOREGULATION DURING INFECTIOUS MONONUCLEOSIS

The objectives of this grant are to characterize the cellular immune responses to Epstein-Barr virus (EBV) and to define the immunoregulatory events important in successful control of EBV infection during acute infectious mononucleosis (IM). We will continue our studies to further characterize the in vivo EBV induced MHC-nonrestricted cytotoxic T-cells (anomalous T-killer cells). The T cell lineage of these anomalous T-killer cells will be established by looking for molecular rearrangement of the T cell receptor genes. We will determine whether these T-killer cells are directed against EBV antigens and test the hypothesis that they are in fact alloreactive T-cells directed at altered class I molecules. Anomalous T-killer cells will be cloned to further prove polyclonality and determine target cell specificities. We plan to investigate the immunoregulatory role of in vivo EBV induced activated helper/inducer T cells. We will use CD4 helper/inducer T cell monoclonals to identify functionally distinct subpopulations. These subpopulations will be functionally studied in assays to evaluate help and suppression of B cell and T cell function. Cloning studies will be attempted to look at function at the clonal level. The long-term objective of our laboratory is to better understand the immunoregulatory events which occur during acute EBV infection. This knowledge will be used to understand immune defects which predispose individuals to fatal infection and lymphoproliferative disorders.